COREGULATION OF ALK8 AND BMP4 IN ZEBRAFISH TOOTH FORMATI

Although the stages of zebrafish development have been well documented, the molecular mechanisms underlying the cellular movements, proliferation and differentiation are not well defined. The zALK-8 (zebrafish Activin Receptor-Like Kinase) gene predicts a protein with a serine/threonine kinase domain similar to other TGF-beta superfamily receptors. Initial characterization of partial genomic clones revealed a conserved intronic sequence between zALK-8 and the zebrafish BMP-4 (Bone Morphogenic Protein) gene. Preliminary immunohistochemical analysis indicates that zALK-8 is developmentally regulated and is coordinately expressed with zBMP-4 during tooth development, positioning it well to play a role in tooth development. We hypothesize that the coordinate expression of zALK-8 and zBMP-4 is essential for normal tooth development. We propose the following specific aims to test this hypothesis. First, we will fully characterize the promoter and intronic sequences of zALK-8 gene to facilitate identification of regulatory domains. Promoter sequences and other conserved domains will then be examined in reporter constructs to identify potential enhancer regions and binding domains for cis-acting elements. The coordinate expression and regulation of the zALk-8 and zBMP-4 genes in tooth development will be examined using reporter constructs of GFP for zALk-8 and YFP for zBMP-4 allowing easy visualization of overlapping and distinct domains of expression.